IL-10 Delivery Using Extracellular Vesicles to Delay Preterm Birth

PROJECT ABSTRACT
Recently released “Born Too Soon” by WHO and many other global organizations (May 2023) reported 152
million preterm births (PTB) worldwide in the past decade, with 15 million neonatal deaths due to prematurity
complications. Current interventions are insufficient to reduce the rates of PTB that involve both the fetus and
the mother as patients; however, interventions are restricted to the maternal uterine tissues and do not address
the fetal inflammatory response, which is one of the major triggers of labor at term and preterm. To address
drug delivery to the fetus and to reduce the fetal and maternal inflammatory response, we have successfully
developed and tested extracellular vesicle (EVs; exosomes) mediated delivery of anti-inflammatory cytokine
interleukin-10 (eIL-10). This approach improves IL-10’s half-life in the body and avoids its intraamniotic
administration for effectiveness. Our laboratory has engineered EVs by electroporation to contain the natural
anti-inflammatory protein IL-10. Engineered EVs retain their normal characteristics and cargo functionally
active IL-10 and show the following: (1) In vitro efficacy to reduce NF-kB activation and inflammatory cytokine
production in vitro in feto-maternal cells, (2) successful transplacental delivery of eIL-10 to delay PTB by over
72 hours in LPS-induced PTB in mouse models with a reduction in histologic chorioamnionitis and fetal and
maternal systemic inflammatory response, and (4) eIL-10 did not cause long term immunosuppression in the
neonates or mothers. Several unanswered questions remain before advancing eIL-10 to clinical trials. We will
test the hypothesis that eIL-10 is safe, stable, and specific in reducing feto-maternal inflammation to delay PTB
without any prenatal or postnatal complications. We will test the hypothesis using the following aims: SA# 1:
Determine PK/PD, toxicity, pregnancy, and neonatal outcomes associated with eIL-10 in pregnant mouse
models. SA#2: Determine the toxicity and PK/PD in non-pregnant and pregnant nonhuman primate models. In
addition, using a 3rd aim, the reproducibility of animal model data of eIL-10 will be tested. We will use a highly
innovative humanized microphysiologic model of the feto-maternal interface that contains interconnected fetal
membrane/placental-decidual interface organs on a chip (FM-PL-OOC). SA#3: To determine the utility of FM-
PL-OOC in defining the propagation, absorption, cytotoxicity, and efficacy of eIL-10. Comparison of data with
Aims 1&2 will validate our in vitro model and validate the use of microphysiologic-based devices for future
preclinical trials. Our approach will enable the use of alternative approaches to animal testing to obtain
regulatory agency approval for the investigation of the safety and efficacy of a drug during pregnancy. This
proposal will yield data from three independent models to define the toxicity, PK, and PD of eIL-10, a novel
interventional strategy to decrease inflammation-associated PTB.

Public health relevance
PROJECT NARRATIVE We have generated a novel approach to deliver a natural antiinflammatory protein (interleukin-10) using naturally occurring human cell-derived extracellular vesicles (exosomes) to reduce the risk of infection and inflammation-induced preterm birth. In mouse models, this drug can cross the placenta to treat the fetus and delay preterm birth with no side effects to the mother or the fetus. Before clinical trials in humans, we will conduct various toxicology studies using two animal models of pregnancy (mouse and nonhuman primates) and validate these results using a newly developed humanized intrauterine pregnancy tissue (organ on a chip; Non-Animal Model) before submitting the drug for FDA approval for clinical trials during pregnancy.